Race and Family Factors in Adolescent Drug Use

DESCRIPTION (provided by applicant): The objective of this proposed research is to investigate family factors and other social contexts in relationship to the perception and use of drugs among African-American and white adolescents. Such information will be useful for the design and implementation of preventive intervention programs for black adolescents. The task of designing preventive interventions for drug problems for black youth is hampered by the fact that more research is needed. While several studies have provided evidence concerning drug use and related problems among black youth, questions remain about some of the factors hypothesized to be critical to the phenomenon of drug use. The proposed research requests two years of funding to investigate differences in the use of drugs and alcohol by black and white adolescents. The proposed study has three broad aims. The first is to investigate the role of parenting behavior and practices for black and white adolescents as a factor in the use of drugs. The second is to investigate how parenting behavior and practices in the context of different family structures may be a factor in the use of drugs for black and white adolescents. Because of possible links with family socioeconomic status (SES), we will also investigate family SES as a factor in adolescent drug use. The third aim is to investigate the possible mediating role of peer use, religiosity and neighborhood cohesion between parenting behavior and practices and drug use for black and white adolescents. This proposed research is structured as a secondary data analysis of existing survey data. The data we propose to use to examine these issues is from the National Longitudinal Study of Adolescent Health (AddHealth), a nationally representative study of adolescents in grades 7 through 12 in the United States in 1995. The study was designed to investigate adolescent health, health behavior and relationships, and other issues. The data are longitudinal in design, and two waves of study data are available. Approximately 20,000 adolescents were surveyed, and additional data is available from the parents of the adolescents.